The role of Fusobacterium nucleatum and Candida albicans interkingdom interactions in promoting OSCC

PROJECT SUMMARY
Oral squamous cell carcinoma (OSCC) exerts a significant clinical and financial burden worldwide. Recently,
there has been increasing interest in the role of the microbiome in OSCC. Among microbial species that have
frequently been identified in association with OSCC and demonstrated to promote oral carcinogenesis, both in
vitro and in animal models, include the bacterium Fusobacterium nucleatum and the fungus Candida albicans.
The two species have been demonstrated to interact via co-aggregation; however, whether such interkingdom
interaction can promote oral carcinogenesis has never been explored The current proposal builds on our
previous studies investigating the microbiome associated with OSCC and oral leukoplakia in clinical samples,
and assessing the effects of oral bacteria against oral epithelial cell lines in vitro. The proposed studies will
investigate for the first time the potentially synergistic interaction between C. albicans and F. nucleatum in
malignant progression, which we hypothesize is facilitated by their coaggregation. Based on our preliminary
data, we also hypothesize that the two species mediate part of their oncogenic properties through upregulation
of INHBA, a proposed oncogene acting through the TGF-β pathway. To address these hypotheses, we propose
to assess synergistic effects of C. albicans and F. nucleatum on normal, dysplastic, and neoplastic oral
epithelium in vitro (Aim 1), and to study the carcinogenicity of C. albicans and F. nucleatum co-carriage in 4-
nitroquinoline-1-oxide-induced OSCC mouse model (Aim 2). Combinations of wild-type, aggregation +ve strains
and mutant, aggregation-deficient strains of the two species will be used in the two aims to assess the role of
co-aggregation in promoting synergistic carcinogenicity. The involvement of INHBA upregulation in this synergy
will be investigated by mechanistic gene knockdown experiments. The project will employ a range of
technologies including cellular and biochemical assays, metatranscriptomics, histopathology,
immunohistochemistry, flow cytometry, q-PCR, fluorescent in-situ hybridization and 16S sequencing to
investigate the effect of treating the cell lines and mice with the test species. This innovative, exploratory study
leverages the complementary expertise of the research team to provide a first insight into the potential role of
interkingdom microbial interactions in OSCC and shed light on novel mechanisms by which C. albicans and F.
nucleatum may contribute to oral carcinogenesis

Public health relevance
Project Narrative Oral cancer is a deadly and debilitating disease that continues to have poor prognosis despite advances in treatment. There is a growing body of evidence implicating the fungus Candida albicans and the bacterium Fusobacterium nucleatum in the development of oral cancer; however, whether the two species interact to promote carcinogenesis is not known. In this application, we employ laboratory and animal experiments to investigate such interkingdom interaction in oral cancer.